SINGLE DOSE OF LOXACIN VS TRIMETHOPRIM-SULFAMETHOXAZOLE IN CYSTITIS IN WOMEN

This study was designed to assess the efficacy of single doses of ofloxacin, a new fluoroquinolone, compared to trimethoprim/sulfamethoxazole in the therapy of uncomplicated cystitis in women.